CORE SUPPORT FOR CANCER RESEARCH CENTER

The Albert Einstein Cancer Center was established in 1972 and has grown from 23 to 100 investigators who currently hold approximately %30 million in direct grant support. The members of the center come from 8 basic science and 10 clinical departments and are organized into 10 established programs in immunooncology, Viral Oncology. Genetic Approaches to Cell Regulation, Receptor Mediated Growth and Differentiation, Growth Control in Malignant Cells, Molecular Membrane Biology, Drug Design and Development, Hematological Malignancies and General Oncology, Cancer Control and Epidemiology and Colon Cancer. Three of these programs are new and the others have been reorganized since the last renewal with new members under new leadership. Other important changes since the last renewal include the appointments of Dr. I. David Goldman as the new Director of the Cancer Center as of November 1, 1995 and Dr. Jeffrey Pollard as the Associate Direct or for laboratory Research in 1994. The Cancer Center supports 15 shared resources. The Animal Barrier, Centralized Protocol and Data management Unit, FACS, Glassware Washing, Hybridoma and Tissue Culture, NMR, Oligonucleotide Synthesis, Protein Analysis and Peptide Synthesis, and Transgenic Mouse facilities existed at the last renewal. The Analytical Imaging, Biostatistical Core. Cytogenetics, DNA Sequencing, Gene Targeting and Scientific Computing have been established since the last renewal. This renewal includes a request for a new shared resource for Tissue Procurement and Processing.